The development of gene therapeutic approaches to suppress cerebral inflammation in dementia

There is an urgent need for the development of new and effective therapeutic approaches to Alzheimer’s
disease (AD). The field of gene therapy has progressed significantly in the last 10 years and is beginning to
enter the clinic for disease treatment. Gene transfer approaches have the advantage of being more targeted to
specific pathways and require far fewer interventions compared to more traditional approaches. In the AD field,
it has become clear that inflammation is a key component contributing to AD pathology. One major route for
inflammation is through activation of inflammasomes, sensors of cellular insults. Therefore, we propose the
development of gene transfer approaches to inhibit inflammasome function. This will be done through the use
of a brain administered dominant-negative (DN) inhibitor of the inflammasome complex (Aim 1) or through the
use of a peripherally delivered brain-targeted DN inhibitor of the inflammasome complex (Aim 2). Adeno-
associated viral (AAV) vectors will be used to facilitate DN inhibitor gene expression as they provide an
efficient and safe vector system. We will use a rat transgenic model of AD-like amyloidosis to test these
approaches and assess learning/memory in addition to neurochemical and immunohistological measure
associated with AD. This proposal will explore novel therapeutic approaches to AD through targeting a key
inflammatory disease pathway in a relevant animal model.

Public health relevance
NARRATIVE The proposal will explore the use of gene therapy to specifically target and inhibit the inflammasome in a rodent model of Alzheimer’s disease. This work will develop novel therapeutic approaches that will form the basis for preclinical studies using gene therapy and biologics to treat neurodegeneration.